Glycomic Modulation of Inflammaging and Immune Functions during HIV Infection

PROJECT SUMMARY: In the general population, IgG glycomic alterations correlate with and drive inflammatory
responses during aging (inflammaging). However, it was previously unknown whether living with antiretroviral
therapy (ART)-suppressed HIV infection is associated with changes in these markers of inflammaging. During
the last funding cycle, we found that living with ART-suppressed HIV infection is associated with an acceleration
in the accumulation of pro-aging IgG glycomic alterations. Specifically, antibodies from people with HIV (PWH)
on ART show a more significant loss of the anti-inflammatory glycans galactose (agalactosylation) and sialic
acid (hypo-sialylation) compared to antibodies from HIV-negative controls. These glycomic alterations were
linked to higher inflammation and increased severity of inflammaging-associated comorbidities in PWH. In a
proof-of-concept study, we also found that these alterations might precede the development of such
comorbidities by years, making them excellent candidates for discovering biomarkers to predict these conditions.
In addition to their associations with inflammaging in PWH on ART, these glycomic alterations during ART
correlated with a faster HIV rebound after stopping ART. Consistently, levels of these glycans correlate with
elevated levels of HIV DNA during ART. This intriguing correlation between these markers of inflammaging and
HIV persistence prompted us to investigate the mechanisms by which these alterations might contribute to larger
HIV reservoirs and greater inflammaging: 1) Agalactosylation: The loss of galactose reduces the ability of IgGs
to elicit Fc-mediated anti-viral innate immune function. This reduced function could result in a larger HIV reservoir
and, consequently, greater inflammation. Our data support this mechanism, as glycoforms of the HIV antibody
10-1074 engineered to lack galactose exhibited significantly lower anti-HIV immune function than glycoforms
with high galactose. 2) Hypo-sialylation: The loss of sialic acid prevents a potent anti-inflammatory mechanism
by myeloid cells. Our data support this mechanism by showing that treating HIV-infected viremic humanized
mice with sialidase inhibitors (to prevent hypo-sialylation) attenuates HIV-mediated inflammation.
Our current aims capitalize on these findings to start delineating their translational potential with the overarching
hypothesis that agalactosylation and hypo-sialylation: 1) can serve as predictive biomarkers for inflammaging-
associated comorbidities in PWH (Aim 1a); 2) are mechanistically linked to HIV persistence and inflammation by
compromising anti-viral innate immune functions (Aim 1b and Aim 2a); and 3) can be normalized to enhance
immunity and inhibit inflammaging (Aim 2a and Aim 2b). In Aim 1 (human samples aim), we will test the
hypothesis that IgG agalactosylation and hypo-sialylation can predict inflammaging-associated comorbidities in
PWH and are linked to compromised anti-HIV innate immune function and a larger HIV reservoir size. In Aim 2
(animal studies aim), we will test the hypothesis that highly-galactosylated IgGs and sialidase inhibition can
enhance anti-viral immune functions and reduce inflammation in HIV-infected ART-treated humanized mice.

Public health relevance
PROJECT NARRATIVE As people with HIV grow older, they face health issues tied to inflammation, such as heart disease and cancer, even when the virus is controlled by antiretroviral therapy. This study aims to figure out what causes this inflammation, hypothesizing that the loss of specific anti-inflammatory carbohydrate molecules (glycans) circulating in the body contributes to the development of HIV-related inflammation, which could lead to associated health problems. The idea is that if changes occur in these glycan structures during the course of living with HIV, understanding these changes could open the door to identifying new biomarkers for predicting age-related illnesses in people with HIV, as well as developing novel strategies to correct these glycans and reduce inflammation.